A double-blind randomized controlled trial to assess the efficacy and safety of a quadruple ultra-low dose treatment for hypertension (QUARTET USA)

PROJECT SUMMARY/ABSTRACT
The proposed application will investigate whether initiating treatment with ultra-low-dose quadruple-
combination therapy (LDQT; including irbesartan 37.5 mg, amlodipine 1.25 mg, indapamide 0.625 mg, and
bisoprolol 2.5 mg) will lower automated office blood pressure and 24-hour ambulatory blood pressure at 12
weeks more effectively, and with no increase in side effects, compared to initiating standard dose monotherapy
(irbesartan 150 mg) in adults with raised blood pressure (SBP>140 mmHg or DBP>90 mmHg) and without
cardiovascular disease. Our preliminary data from a short-term (4-week) crossover trial of 18 participants
suggest that LDQT lowers office blood pressure by 22/13 mmHg on average compared with placebo with no
difference in serious adverse events. Effects on 24-hour ambulatory blood pressure were similar.
We will perform this phase II, single site, randomized controlled trial in a network of federally qualified
health centers in Chicago because this population bears a disproportionate burden of blood pressure related
diseases, and we have previously successfully conducted clinical studies in this population. This new and
simpler treatment paradigm has potential to eliminate blood pressure disparities in this population, which
provides the motivation for this proposal. While we hypothesize this intervention will be easily implemented and
efficacious for all patients and clinicians, we will explore variation in treatment effect by potential moderating
variables, including age, sex, race/ethnicity, and health literacy level. Beyond examining efficacy, we also plan
to assess feasibility of implementing this intervention in a clinical setting by simultaneously evaluating
implementation outcomes of acceptability, preferences, and lessons of LDQT among patients and clinicians.
Two early stage investigators will lead the study team with relevant, complementary clinical trial experience
in cardiovascular medicine and biostatistics, which provide a strong foundation for this proposal. Our team will
leverage internal and external experience and resources in cardiovascular research, combination drug therapy,
and implementation science to study a novel intervention in a high-burden, low-resource population from a
single site through this phase II trial. We plan to pool the present trial data with that of similar trial conducted in
Australia (led by one of the study team members in this proposal) to examine the robustness and
generalizability of our study results.
Relevance
This proposal aims to create, evaluate, and demonstrate successful implementation of an ultra-low dose
quadruple combination drug therapy that is simpler, more efficacious, and safer than standard therapy for
patients and their doctors. If successful, then the proposal will lay the framework for a larger multi-site phase III
randomized controlled trial with goal of confirming efficacy and safety in a larger population, with the ultimate
goal of a complete change the paradigm for initial blood pressure lowering therapy.

Public health relevance
PROJECT NARRATIVE High blood pressure is a leading cause for heart diseases and stroke in the United States; however, only half of hypertensive Americans have their blood pressure controlled using a goal blood pressure of <140/<90 mmHg, despite wide availability of low-cost, effective drugs. Our proposal aims to create, evaluate, and demonstrate successful implementation of an ultra-low dose quadruple combination drug therapy that is simpler, more efficacious, and safer than standard therapy for patients and their doctors. We plan to conduct a phase II randomized controlled trial in which we will simultaneously evaluate implementation success of this strategy in a high-burden, low health literacy population with a goal of rapidly translating our research findings into clinical practice.